Perceptions and Experiences of Adult Women Aging with the Diagnosis of Schizophrenia Spectrum Disorders in Relation to Social Connectedness

ABSTRACT
The mental disorder of schizophrenia is often debilitating, affecting cognition, behavior,
perception, and speech. Adults aging with the diagnosis of schizophrenia spectrum disorders
are a vulnerable population, with unique, complex problems that include multiple physical and
psychological co-morbidities. Factors associated with increased morbidity and mortality are
frequently identified in this population, individuals who are often reported to live 20 years less
than peers who are not diagnosed with their condition. Their early mortality and increased
morbidity have been linked to social isolation and loneliness. In our pilot exploratory interviews
with these individuals from May 2021 to May 2022 (N = 10 state hospital and 20 nursing home
residents), many adult women aging with schizophrenia spectrum disorders stated that they felt
alone and reported a need for increased social engagement and connectedness in their
institutionalized settings (Walker, 2023; Walker & Harrison, 2023). We view them to be experts
in their own health care, and we are further seeking their perceptions to better understand social
connectedness from their viewpoint. In this project, we explore (a) the life course experiences of
institutionalized adult women aging with a diagnosis of schizophrenia spectrum disorders with a
focus on their experiences of social connectedness, (b) their perceptions of how social
connectedness is approached in their institutionalized settings, and (c) their perceptions of how
social connectedness could be improved in their institutionalized settings. Homogeneous
purposive sampling and qualitative analysis of interviews will be used to determine factors
related to participants’ perceptions. Our overall purpose is to inform interventions to decrease
loneliness and social isolation and to improve social connectedness in adult women aging with
the diagnosis of schizophrenia spectrum disorders in institutionalized settings. This small, self-
contained research project represents a step in assisting healthcare professionals to improve
health care outcomes among adult women aging with the diagnosis of schizophrenia spectrum
disorders, promoting both their physical and mental health as part of a long-term project to
improve their quality of life and provide solutions to the complex problems associated with their
condition.

Public health relevance
Project Narrative: Increasing numbers of adult women aging with schizophrenia spectrum disorders are living in institutions, and many have reported feelings of isolation and loneliness. In this research project, we will explore their perceptions and experiences in order to inform care interventions and programs to improve their social connectedness in institutionalized settings.